The UNC inTelligen And Machine lEarning (TAME) Training Program

PROJECT SUMMARY PARENT AWARD The parent award for this administrative supplement is the T32 training grant at the University of North Carolina (UNC) at Chapel Hill for Pre- and Postdoctoral Training in Toxicology to support the development of future investigators in environmental health and toxicology. This training program is led by Dr. Ilona Jaspers and supports 8 predoctoral and 3 postdoctoral trainees at UNC, with the current award period continuing until June 2023, at which point we will submit another application for continued renewal. The training program brings together a highly interactive and productive faculty of basic scientists, physician scientists, and public health researchers from the UNC Schools of Medicine, Public Health, and Pharmacy, plus outstanding researchers and mentors from the U.S. Environmental Protection Agency (US EPA) and National Institute of Environmental Health Sciences (NIEHS) in Research Triangle Park, North Carolina. The training program faculty includes 43 investigators with proven research records in environmental health and toxicology. Our overall mission is to train predoctoral and postdoctoral trainees to integrate basic toxicology with next-generation research tools to advance environmental health and toxicology knowledge in the 21st century. Our current research training focuses on providing predoctoral and postdoctoral trainees the environment, infrastructure, and resources to conduct interdisciplinary cross-cutting research in environmental toxicology, systems toxicology/biomarkers, research translation, and animal models of human diseases. Trainees from this program have gone on to productive careers in academia, government, and industry. In order to maintain this successful training program, we continuously update our training approaches, incorporating feedback from our external advisory committee and other forms of training program evaluation. The program continues to have outstanding didactic instruction, excellent training and mentoring oversight, unparalleled resources, and an outstanding environment to support the training of the next generation of environmental health scientists and toxicologists.

Public health relevance
PROJECT NARRATIVE PARENT AWARD This interdisciplinary training program is designed to provide the necessary resources, infrastructure, and research opportunities for predoctoral and postdoctoral trainees interested in toxicology and environmental health effects on human diseases. The goal of the Curriculum in Toxicology at UNC-CH is to train new scientists that are able to enhance our understanding of how the environment affects human disease.